Mobile technologies to screen for prediabetes and type 2 diabetes in asymptomatic adults

PROJECT SUMMARY/ABSTRACT
Prediabetes (PD) and type 2 diabetes (T2D) affect 122 million Americans. Although diabetes is the most costly
chronic condition in the US—with an annual economic burden of $327 billion—it is severely underdiagnosed,
with 84% of those with PD and 21% of those with T2D unaware of their condition. Screening guidelines for PD
and T2D include coarse self-reports with low positive predictive value, and therefore have been unable to
mitigate this severe diagnostic gap. The ultimate goal of this research is to develop and implement an innovative,
practical, and scalable PD and T2D detection strategy by leveraging digital data obtained using personal
consumer smart devices (smartphones and smartwatches). Smartphones and smartwatches are now prevalent
in the general population, and the technology developed here will be directly translatable for immediate
deployment to improve the detection of PD and T2D. Toward this goal, we recently developed wearable-based
models using a research-grade wearable wristband to detect personalized glucose deviations, predict interstitial
glucose values, and estimate the level of glycated hemoglobin (A1c), which are all key metrics for detecting and
monitoring PD and T2D. The wearable-based models currently function on people with a limited A1c range
(prediabetic and elevated normal). To translate this work and expand the reach and yield of current screening
methods, we propose the following two Specific Aims: (1) Validate and extend the wearable models to
distinguish between T2D, PD, and normoglycemia; and (2) Determine how we can leverage smartphones and
smartwatches to improve the yield and reach of present screening methods for PD and T2D. In the first Aim, we
will validate and extend our preliminary work developing the wearable models to function across a wider range
of glycemic variability, interstitial glucose, and A1c values and to move from research-grade wearables to
consumer-grade smartwatches. In the second Aim, we will expand the reach of current guideline-based
screening using text message delivery of the American Diabetes Association (ADA) “60-second Risk Test” to
directly assess and inform patients about their risk for PD and T2D with the goal of increasing A1c testing in
patients that meet the risk criteria. We will increase the yield of true positives by adding objective smartwatch
and/or smartphone measures (e.g., physical activity, sedentary habits, glycemic health parameter estimations)
to the existing ADA 60-second Risk Test model. The innovations from this proposed research could transform
PD and T2D detection for the 81 million Americans with undiagnosed PD and T2D through novel methods for
real-time, continuous mobile screening. Successful completion of this project could ultimately revolutionize
diabetes management by improving early detection and by enabling proactive intervention to prevent or reverse
T2D progression.

Public health relevance
Prediabetes (PD) and type 2 diabetes (T2D) affect 122 million Americans and are critically underdiagnosed— 81% and 23% of those with PD and T2D, respectively, are unaware that they have the condition. Screening guidelines for PD and T2D have been unable to mitigate this severe diagnostic gap due to their coarseness, subjectivity, and poor performance (e.g., low positive predictive value). The ultimate goal of this research is to develop and implement an innovative, practical, and scalable PD and T2D detection strategy by leveraging digital data obtained using personal consumer smart devices (smartphones and smartwatches) to improve the yield and reach of PD and T2D screening.